Examining the integration of inputs by the subiculum during virtual navigation

DESCRIPTION (provided by applicant): Spatial navigation in rodents is a widely used paradigm for studies of cognition, learning, and memory in the mammalian brain. The subiculum is an important output structure for circuits that underlie navigation, yet few studies have examined its physiology in behaving animals. This proposal aims to identify how an individual subiculum neuron integrates information during navigation from its pre-synaptic inputs in the CA1 region of the hippocampus. CA1 neurons form a spatial map of the environment that is sensitive to small changes; for example, moving from a circular chamber to a square chamber can drastically alter the representation in CA1. The subiculum, on the other hand, seems to form stable maps that do not undergo substantial changes in different environments, despite receiving a major input from CA1. How the subiculum maintains a stable representation remains an open question. To investigate these mechanisms in the context of navigation, the Tank lab has recently developed new technology for calcium imaging and electrophysiological recordings to be performed in the brain of awake mice during navigation in a virtual environment. This technology consists of a spherical treadmill that allows for motion in two dimensions, a virtual reality environment controlled by the motion of the animal on the spherical treadmill, and interchangeable equipment allowing for either electrophysiological recordings or optical imaging. A major advantage of this experimental setup over conventional methods for studying navigation is that the animal is head-fixed, yet allowed to navigate within a virtual environment, providing stability for calcium imaging or whole cell recordings. It is also advantageous because the virtual environment can be dynamically altered during navigation tasks, providing complete control over the animal's experience. This proposal takes advantage of these new technologies in order to understand how the subiculum forms a map of the environment. In aim 1, optical imaging of calcium activity will be used to characterize what kinds of environmental alterations change the CA1 representation but preserve the map in the subiculum. Aim 2 will address the anatomical organization of subiculum circuitry by tracing mono-synaptic inputs to a single subiculum neuron. These neurons include inputs from CA1 and recurrent connections within the subiculum. In aim 3, these techniques will be combined in a single animal. The spatial representation in individual subiculum neurons will be compared to the representation of mono-synaptic inputs in CA1 and subiculum. This comparison will shed light on how subiculum neurons integrate incoming signals to form a stable representation. Unraveling this computation will help to understand the role of the hippocampal formation more generally.

Public health relevance
PUBLIC HEALTH RELEVANCE: The subiculum plays an important role in cognition, learning, and memory in the mammalian brain. Many health problems are associated with disruption of the subiculum, such as Alzheimer's disease, schizophrenia, epilepsy, and drug addiction. Understanding how microcircuits in the subiculum operate will provide a template for assaying when it is altered by disease states. __SpecificAimsTextDelimiter__ Specific Aims ! A fundamental feature of neural processing is how each neuron integrates its inputs to produce a distinctive pattern of activity during behavior. However, few techniques can directly address how anatomical connectivity relates to functional properties at the level of an individual neuron. This proposal aims to measure, for the first time, behaviorally-evoked responses of a single neuron and a large ensemble of inputs to that neuron identified as forming direct synaptic connections. This will be achieved by combining refinements of two recently developed methodologies: optical recording of calcium transients in mice navigating a virtual environment, and anatomical tracing of mono-synaptic inputs to a single neuron using a modified rabies virus. ! This technique will be developed in the subiculum, the major output of the hippocampal formation. The subiculum primarily receives input from entorhinal cortex (EC) and the CA1 region of the hippocampus, but it is unclear how subicular activity is related to these input populations. Understanding how subiculum place fields are computed would more generally illuminate whether the subiculum simply relays information to targets outside the hippocampal formation, or if it instead performs substantial processing on the signals it receives. Once developed in the subiculum, this technique will be generalizable to nearly any brain region that is optically accessible, opening up many possibilities for studies of behaviorally evoked activity in the context of known neural microcircuitry. Aim 1. Characterize how place fields in the subiculum and CA1 encode multiple virtual environments. Motivation: Despite the importance of the subiculum in the hippocampal formation, few studies have characterized its physiological activity. A promising means to characterize place field organization is a methodology recently developed in the Tank lab: mice running on a spherical treadmill are trained to navigate a virtual environment, and neural activity is monitored by imaging the calcium-indicator GCaMP3 through a cranial window. Experiments: A window will be implanted at the border between the subiculum and CA1 to provide optical access to both regions in a single mouse. Place fields will be characterized in dozens of simultaneously recorded neurons while a mouse explores multiple virtual environments. These recordings will be used to identify which alterations to a virtual environment are necessary to induce place field remapping like that observed for distinct real environments. Other functional properties will be characterized as well, such as whether nearby cell bodies tend to exhibit similar place fields. Aim 2. Identify a large collection of monosynaptic inputs to a single subiculum neuron. Motivation: It remains an open question how individual subiculum neurons sample incoming fibers from CA1, EC, and other areas. A technique has been recently introduced to infect a single neuron with a modified rabies virus, thus labeling that neuron and a subset of its monosynaptic inputs. However, this technique labels only 1-10% of inputs. A leading hypothesis is that the low efficiency stems from a limited supply of glycoprotein used to assemble virus particles. Experiments: A single subiculum neuron will be targeted for mono-synaptic tracing with rabies, and its input neurons characterized anatomically. To improve the efficiency of labeling, a novel strain of AAV will be created and incorporated into the rabies tracing technique to produce a larger store of glycoprotein; greater availability of glycoprotein will likely increase the number of virus particles, thus labeling a substantially greater fraction of inputs and revealing novel features of subiculum organization. Aim 3. Compare the place field of a subiculum neuron to the place fields of mono-synaptic inputs in CA1 and subiculum. Motivation: How much does the subiculum process and modify information from CA1 and EC before sending it on to external brain regions? Subiculum place fields likely arise from a combination of EC and CA1 place fields as well as recurrent connections within the subiculum. Comparing the balance of internal and external contributions will address whether the subiculum simply sums external inputs or instead performs a more substantial computation. Experiments: Techniques from Aims 1 and 2 will be combined in a single animal. Mice trained to navigate a virtual environment will be implanted with an optical window to visualize neurons expressing GCaMP3 in the subiculum and CA1. In the same mice, a single subiculum neuron and its mono-synaptic inputs will be labeled using the technique described in Aim 2. While a mouse navigates multiple virtual environments, place fields will be measured in the initially infected cell and the retrogradely labeled cells. Comparing these place fields will help to distinguish whether the subiculum acts a simple relay or instead performs a more complex transformation of CA1 inputs.